Novel mechanisms of purine regulation and their roles in human pathophysiology

PROJECT SUMMARY
Mitochondria regulate essential biological activities through their effects on cellular metabolism, particularly via
oxidative phosphorylation (OXPHOS). Mitochondrial dysfunction leads to numerous human pathologies,
including neurological disorders, autoimmune diseases, and cancer. However, while permanent impairment of
the electron transport chain (ETC) in human tissues is detrimental, reversible suppression of OXPHOS is integral
to some physiological processes, such as the activation of inflammatory responses in macrophages. Metabolic
dysregulation in macrophages can either weaken their anti-microbial strength or drive inflammation to
pathological levels. Therefore, defining the context-specific metabolic consequences of OXPHOS suppression
is crucial for identifying the mechanistic basis of mitochondrial diseases and pathological inflammation. Previous
studies, including mine, have shown that under conditions of suppressed OXPHOS, both ETC-deficient cancer
cells and proinflammatory bone marrow-derived macrophages (BMDMs) exhibit suppressed de novo purine
biosynthesis and increased purine salvage. Although enhanced purine salvage maintains nucleotide pools in
response to ETC deficiency-induced DNPB suppression in vitro, it is unclear if this mechanism operates under
in vivo conditions with more relevance to human health, including tumors and splenic macrophages. My recent
work demonstrated that ETC deficiency potentiates purine salvage through increasing the levels of HPRT1
substrate, phosphoribosyl pyrophosphate (PRPP) via the pentose phosphate pathway (PPP) in cultured cancer
cells. However, the molecular mechanisms promoting purine salvage and their impact on inflammatory signaling
in macrophages are unknown. The overarching objective of this proposal is to elucidate molecular mechanisms
underlying purine salvage regulation in response to suppressed OXPHOS under both pathological (e.g., ETC-
deficient tumors) and physiological (e.g., inflammatory macrophages) conditions. Building upon my previous
study, I will test the central hypothesis that ETC deficiency enhances purine salvage in tumors and inflammatory
macrophages to support cell growth and function. In Aim1, I will test whether ETC-deficient tumors enhance
purine salvage and utilize environmental nucleobases to maintain cellular purine nucleotide pools in vivo. In
Aim2, I will characterize the role of purine salvage in inflammatory macrophages. Specifically, I will test if purine
salvage is enhanced via the increased PPP to promote innate immune responses in BMDMs upon inflammatory
stimulation. I will also characterize the role of purine salvage in splenic macrophages in vivo during systemic
inflammation. Taken together, the proposed study will advance our understanding of purine nucleotide regulation
in vivo under conditions of suppressed OXPHOS and facilitate the development of novel therapeutic strategies
to treat patients with mitochondrial defects, purine abnormalities, or pathological inflammation.

Public health relevance
PROJECT NARRATIVE Metabolic dysfunction can give rise to a wide range of human diseases, such as neurological dysfunction, myopathies, autoimmune disorders, and cancer. However, the precise metabolic reprogramming that occurs in these pathologies remains largely elusive. The proposed research aims to investigate the regulation and impact of purine metabolism in the context of mitochondrial and inflammatory diseases, with the ultimate goal of generating new insights into the development of innovative therapeutic strategies to treat these conditions and enhance public health.